Mentoring in Community-engaged Research to Promote Health Equity for Latinos

Dr. Page is an Associate Professor of Medicine and infectious disease specialist engaged in clinical care, and
public health research with a focus on expanding access to care for marginalized populations through
community-engaged program building and evaluation. Over the last 15 years, her research has focused on: 1)
Elucidating the impact on health of stressors associated with migration and poverty; 2) Implementing and
evaluating culturally and linguistically adapted interventions to improve access to care and utilization among
underserved populations; and 3) Bridging the gap between scientific advances and real-world implementation
to reach communities at highest risk of disease. She is the co-founder of Centro SOL (Center for Salud &
Opportunities for Latinos), and has established a community coalition that has developed culturally and
linguistically appropriate interventions to reduce health disparities among low-income limited Englih proficiency
Latino communities. The objectives of this application are to support a program for mentoring junior
investigators interested in health disparities, and to foster innovative epidemiology and implementation science
research through interdisciplinary and community-engaged approaches. The research strategy proposed in
this award capitalizes on existing multi-stakeholder community-academic-public health partnerships, as well as
the infrastructure of Centro SOL and multiple independently funded research studies. This Mid-Career award
explores the multi-level barriers and facilitators of engagement in healthcare and research through peers and
technology (hybrid methods) that leverage social networks, mobile health (mHealth) and trusted community
health workers. Informed by the Information-Motivation-Behavioral Skills model (IMB) and Social Network
Theory, Aim 1 will determine the efficiency and acceptability of hybrid methods to promote healthcare
engagement among low income LEP Latinos. In Aim 2, the study will determine the efficiency and acceptability
of using hybrid methods for recruitment, data collection, and research engagement among Latinos by
comparing traditional convenience sampling approaches to sampling using technology-based methods. Using
the Consolidated Framework for Implementation Research (CFIR) and Research Effectiveness-Adoption
Implementation Maintenance (RE-AIM) framework, semi-structured interviews will be conducted with key
stakeholders to assess and inform implementation determinants and outcomes of hybrid methods to inform
future broad scale implementation (Aim 3). This proposal creates a platform for trainees to learn and apply
skills in community-based research, implementation science, mHealth, network analysis, epidemiology, and
health disparities. This work also seeks to improve diversity, equity, and inclusion in research by prioritizing
community engagement and training opportunities for early-stage investigators who are under-represented in
medicine and health-related sciences

Public health relevance
Dr. Page conducts research addressing barriers to evidence-based care to vulnerable populations through community-engaged program building and evaluation. The objectives of this proposal are to support a program for mentoring junior investigators and to foster innovative epidemiologic and implementation science research. The overall goal of this work is to train a diverse new generation of health equity researchers and to bridge the gap between knowledge and practice by ensuring that medical and research advances are available to those who need them the most.